Project 1 - Longitudinal study of thrombotic thrombocytopenic purpura

PROJECT SUMMARY – PROJECT 1
The overarching goal of this project is to develop the first multicenter, prospective, longitudinal study of
immune-mediated thrombotic thrombocytopenic purpura (iTTP) and the extremely rare congenital TTP (cTTP).
In survivors of both diseases, long-term complications include relapses, cognitive dysfunction, mental health
disorders, and stroke. It is also likely that cognitive dysfunction is progressive, but the mechanism and tempo
of this sinister but subtle phase of these diseases is not well understood. Similarly, relapse can be
unpredictable, creating stress and poor quality of life, and likely contributes to mental health disorders.
Rituximab, the current standard of care for immunosuppression in iTTP, is far less effective than once thought,
suggesting a critical need for more tailored approaches for iTTP. Two advances in the acute treatment of iTTP
and cTTP include caplacizumab and recombinant ADAMTS13, respectively, but how these shifting treatment
paradigms will impact the natural history of these complications is unknown and will be critical to establish.
This project will address these important questions for the long-term health and quality of life of survivors by
creating the first longitudinal study of iTTP and cTTP to evaluate long term risk of cardiovascular disease,
relapse, and cognitive dysfunction, as well as a sub-study of annual MRI scans of the brain and cognitive
testing to evaluate the incidence of silent cerebral infarcts and progression of cognitive dysfunction. We aim to
enroll 500 participants, including both adults and children in our longitudinal study of iTTP, collecting clinical
data on relapses, ADAMTS13 activity, treatment, comorbidities (including vascular diseases in particular),
patient-reported outcomes and quality of life measures. We will also enroll 100 participants with cTTP from
participating centers and from around the country by recruiting participants in the International hereditary TTP
registry living in the US. In aim 2, we will study subpopulations of subjects with iTTP and cTTP to establish the
incidence and risk factors for incident silent cerebral infarct occurring during clinical remission and identify
whether this is a risk factor for stroke in participants with iTTP and cTTP. We stand at the precipice of what we
expect to be a highly innovative next decade in these diseases, with the recognition that current therapies are
inadequate to protect against relapse and likely against progressive neurological dysfunction, but also where
novel therapies are in development and their impact on short- and long-term outcomes needs to be
established.